Multiscale Systems to Elucidate Susceptibility and Cardioprotective Mechanisms in Cardio-oncology

PROJECT SUMMARY (OVERALL)
The overarching goal of this Program Project Grant (PPG) is to elucidate mechanisms of cardiotoxicity
and to develop a platform to test cardiotoxicity of new cancer therapeutics. Project 1 (Moslehi) will use
a combination of mouse- and cell-based models to address the central question of whether
cardiotoxicity associated with ibrutinib is on- or off-target. Project 2 (Wu) will establish novel pooled
“cell villages” from patients to map genetic inter-individual difference in response to kinase inhibitors to
elucidate genetic susceptibility to cardiotoxicity from kinase inhibitors. Project 3 (Mercola) aims to
identify mechanisms that protect against cardiotoxicity of ibrutinib using a pipeline for discovery of
protective targets based on reverting epigenomic consequences of exposure to a toxic drug. All three
projects will be supported by an iPSC Processing Core (Core B) (Sallam) that will facilitate a unique
repository of iPSC lines from patients with ibrutinib treatment. An Administrative Core (Wu) will
support all three projects and the core to facilitate a fully integrated program project and enable high-
impact research. The proposed PPG and assembled group collectively introduces synergies that will
significantly impact the field of cardio-oncology and make translationally actionable inroads to decrease
the burden of adverse effects of cancer therapeutics.

Public health relevance
PROJECT NARRATIVE (OVERALL) New targeted cancer drugs have transformed care for patients, but they can lead to heart disease as an unintended consequence for some patients. This Program Project uses a synergistic, multi-disciplinary approach using mouse- and cell-based models to understand how heart-related side effects occur and to create a new platform for testing future therapeutics. This ultimately has critical implications for precision medicine to better manage cancer patients who could be susceptible to side effects resulting from cancer therapeutics.